Core C. Communication and Dissemination Core

PROJECT SUMMARY/ABSTRACT – Core C: Communication and Dissemination Core
Core C’s primary role is to disseminate research, data and other shared outputs championed by CEDA and its
affiliates. Audiences include CEDA affiliates, other academics, non-academic institutions domestically and
internationally, as well as media and policymakers worldwide. The rich power of its signature projects, such as
the National Transfer Accounts (NTA), provides a wealth of policy-relevant research of external interest.
Objectives of Core C include maintaining and continually upgrading the CEDA website, and using an
innovative set of communications approaches to promote CEDA activities, achievements, publications, and
shared data resources. Innovation will include focused efforts to further cultivate relationships with policy
audiences in two-way dialogues to both share results of interest with the policy community as well as continue
to learn how to better design studies and research products that clearly address their interests.